Training Program in Personalized Cardiovascular Medicine (TPIPCVM)

TRAINING IN PERSONALIZED CARDIOVASCULAR MEDICINE (TPIPCVM)
Project Summary
Cardiovascular disease (CVD) remains a major cause for significant morbidity and mortality in the
U.S. especially in ethnic minorities with their high burden of risk factors. Personalized medicine is a
rapidly growing field of healthcare whereby an individual's unique genomic, environmental and clinical
background is analyzed to ascertain susceptibility to disease, predict their clinical course and tailor
specific therapies. Despite recent advances in CV genomics, our inability to target therapy to
underlying mechanisms in individual patients, the failure to translate these scientific discoveries to the
bedside care of patients and barriers to the incorporation of ethnic minorities in translational CV
research have limited our ability to fulfill the promise of personalized medicine. Furthermore,
traditional training programs are no longer able to provide trainees with the requisite skills needed to
implement the personalized medicine revolution underway. Thereby, major goals of the Training
Program in Personalized Cardiovascular Medicine (TPIPCVM) are to equip trainees to become
leaders in CV Genomics and be trained in molecular, cellular, disease and whole animal modeling
and clinical and translational approaches to CVD so that this new knowledge can be translated into
best evidence-based personalized CV care. We will recruit highly talented and motivated pre- and
post-doctoral trainees and provide them with the highest caliber training in CV genomics stemming
from existing strengths of our faculty in the Division of Cardiology and our partners at UIC. The 3
Research Focus Groups: 1) Cardiac arrhythmias; 2) Ischemic and non-ischemic cardiomyopathy; and
CVD-related metabolic syndrome are highly interrelated with each other and directly linked with the
central theme of Personalized CV Genomics. The overarching goal of the TPIPCVM is to train the
next generation of CV investigators to create new knowledge and implement into best evidence-based
personalized medicine. The TPIPCVM mentors are highly successful physician-scientists/scientists
with a proven record of research, mentoring and collaboration who offer superb inter- and multi-
disciplinary training opportunities. Major strengths of this training program include: exposure of
trainees to an integrated basic science molecular, cellular, and whole patient approach to identify the
underlying mechanisms of CVD; the track record of the faculty and their common research interest in
Personalized CV Genomics; dedicated training in personalized CV medicine; and the potential to
implement scientific discoveries to a diverse and under-represented population of patients cared for at
UIC Medical Center. The TPIPCVM sets out to train 2 pre-doctoral and 2 post-doctoral students
annually. Collectively, this Training Program offers a unique training experience and fulfills an urgent
need for training in personalized CV medicine.

Public health relevance
Project Narrative The Training Program In Personalized Cardiovascular Medicine (TPIPCVM) provides support for the training of basic and physician-scientists before and after their doctoral degrees. The central theme of the training program is cardiovascular genomics with a focus on abnormal heart rhythms (arrhythmias), weakened heart muscle (cardiomyopathies) and heart disease related the being overweight (metabolic syndrome) and how we can translate these discoveries to the bedside care of patients. The program will prepare future researchers for the unique challenges associated with treating patients with heart disease in an individualized manner.